Role of Piezo1-controlled Prox1 Modification in Lymphatic Valve Formation

PROGRAM SUMMARY
Our proposal aims to elucidate how lymphatic endothelial cells detect external fluid forces and convert these
signals into a biological program that orchestrates lymphatic valve formation. We are particularly focused on the
role of Piezo1, a mechanosensitive ion channel in lymphatic endothelial cells, in sensing bidirectional oscillatory
fluid flow and activating downstream effectors. This activation leads to a post-translational modification of Prox1,
the homeodomain transcription factor critical for lymphatic development. We hypothesize that this specific
modification of Prox1 is essential for the formation of lymphatic and lymphovenous valves, as the modification
alters its transcriptional activity by affecting protein stability and binding affinity with partners. The primary goal
of this project is to deepen our understanding of how Prox1 activity is influenced by mechanical stimuli and to
understand the functional implications of these modifications in lymphatic valve development. Our approach will
incorporate a range of methods including in vitro experiments, ex vivo assays, and innovative animal models,
including mutant and transgenic mice, to test the central hypothesis. This research seeks to uncover the essential
molecular mechanisms that control lymphatic development and may identify new therapeutic targets for treating
lymphatic-related disorders. We anticipate that our findings will provide fresh insights into the molecular
underpinnings of lymphatic anomalies and valve dysfunctions, potentially offering the development of targeted
treatments for lymphatic malformations and other related vascular conditions.

Public health relevance
PROGRAM NARRATIVE Our proposal investigates how lymphatic endothelial cells detect and respond to external fluid forces through the mechanosensitive ion channel Piezo1, leading to crucial post-translational modifications of the transcription factor Prox1. We aim to explore how these modifications influence lymphatic and lymphovenous valve formation, by employing a range of advanced methodologies. This research is expected to uncover fundamental mechanisms of lymphatic valve development and identify potential therapeutic targets for treating lymphatic disorders.